Establishing a unified evaluation and implementation framework to inform heat-health warning systems

Project Summary
Research: Extreme heat poses a considerable, ongoing health threat under climate change. Heat alerts inform
local government officials and the public about upcoming extreme heat events, enabling them to take
preventive measures in the hope of reducing health risks associated with extreme heat. Previous studies
examining the health benefits of current heat warning systems showed inconsistent and inconclusive results.
Therefore, Dr. Xiao Wu will develop (1) an evaluation framework to assess the effectiveness of heat warning
systems that will address specific challenges embedded in associated space- and time-varying data and (2) an
implementation framework to inform when and where to issue heat alerts to maximize health benefits. The
proposed method developments, incorporating natural experimental and policy learning approaches, will
provide methodologically robust frameworks for evaluating and implementing heat-health warning systems in
practice. The frameworks developed will be used to study the causal effects of heat alerts on daily, cause-
specific health outcomes for heat-related illnesses using (1) death and hospital admission records from a
national Medicare cohort of adults aged 65 and older, who are particularly vulnerable to extreme heat, and (2)
death records from New York State residents across all age groups. The research outcomes will provide
actionable recommendations for the development of improved heat-health warning systems. The development
of these methods, coupled with open-source software and community partnership building, will expedite public
health responses to extreme heat and increase extreme heat resilience in communities.
Career Development and Training: Throughout his prior training, Dr. Wu has developed highly quantitative
skills in biostatistics and data science. This K01 award will provide him with critical training required for his
transition to an independent researcher specializing in statistical and causal inference methods that address
broad methodological needs in environmental and climate-relevant health research. With this award, he will
pursue domain expertise in climate science and disaster policy, further expand his quantitative skills with
statistical methods and software in policy and reinforcement learning, and learn risk communication and
community-engaged research methods to enhance dissemination and implementation of research outcomes.
Goal: Dr. Wu will build an independent research program to advance causal inference methods for quantifying
the mitigation effects of emerging climate adaptation strategies on health and guiding evidence-based
implementations to improve health. This K01 award will provide him with protected time and focused training to
accomplish his proposed research, establish him as a leading environmental health biostatistician and data
scientist who is well-versed in climate science and policy, and enable him to compete successfully for R01
funding opportunities.

Public health relevance
Project Narrative Extreme heat poses a considerable, ongoing health threat under climate change, and effective heat warning systems are needed to reduce public health risks. The health benefits of current heat warning systems are uncertain; thus, there is a pressing need for robust methods that accurately assess the impacts of heat warnings on health and provide actionable recommendations for the development of improved heat warning systems. I will develop a unified framework that combines causal inference methods, open-source software, and community partnership, which will equip academic researchers, community practitioners, and government officials the methodological tools to evaluate and implement improved heat-health warning systems, thus expediting policy actions in public health responses to extreme heat.